ACE2 on gut barrier dysfunction and BRB disruption

The overarching goal of this project is to determine the role of angiotensin converting enzyme 2
(ACE2) in the diabetic gut, how it impacts hyperglycemia and glycemic variability, and thus contributes to
the pathogenesis of diabetic retinopathy (DR). The protective arm of the renin angiotensin system (RAS)
consists of ACE2, which converts angiotensin II (Ang-II) to angiotensin 1-7 (Ang-1-7). Ang-1-7 opposes
the effects of Ang-II by virtue of its actions on the MAS receptor. While the systemic (endocrine) RAS
works with local (tissue) RAS such as that in the eye and gut to achieve homeostasis in health, in
diabetes loss of key components of the protective RAS can lead to widespread pathology. The literature
and our preliminary data support that diabetes results in loss of expression of ACE2 in the gut, bone
marrow, and retina. Glycemic variability is implicated in DR pathogenesis. Intestinal ACE2 can regulate
glucose homeostasis by modulating tryptophan absorption and incretin release and by generating Ang 1-
7 from luminal Ang II. Ang 1-7 by binding to Mas receptor can block glucose transport in the gut similar to
what has been described in the pancreas. Based on this, we hypothesis: In T2D, loss of enterocyte
ACE2 decreases: i) tryptophan
uptake and incretin secretion
leading to hyperglycemia; ii) MAS
receptor activation increasing gut glucose absorption; and iii) gut barrier integrity resulting in
leakage of gut microbial peptides into the circulation. All three mechanisms increase retinal
permeability and activating immune cells promoting DR pathology. Aim 1 will test if dysregulation of
ACE2 in the gut epithelium results in i) interruption of tryptophan transport by B0AT1 decreasing incretin
secretion and ii) reduced MAS receptor activation leading to increased glucose absorption in the gut.
Aim 2 will test if in db/db mice, loss of intestinal ACE2 will result in increasing circulating levels of gut
microbial peptides that will activate TLRs on retinal endothelial cells and lead to increased retinal
leukostasis and blood retinal barrier dysfunction. Aim 3 will examine if nutraceuticals or probiotics can
restore the balance of the intestinal RAS (ACE2/Ang-1-7/MAS) in db/db mice to prevent development of
DR. Impact: We propose a novel mechanism for deterioration of glucose homeostasis and increased
glucose variability in diabetes- the loss of function of the ACE2:B0AT1 oligomer form of ACE2 (unique to
the intestinal epithelium) and reduced levels of intestinal Ang 1-7 resulting in less intestinal MAS receptor
activation. The dysregulated intestinal RAS can lead to serious retinal pathology promoting DR.

Public health relevance
PROJECT NARRATIVE In this application, we will examine how the retina and the gut communicate and how this communication is altered by the presence of type 2 diabetes. We will study how the loss of a critical protein, angiotensin converting enzyme 2 (ACE2), in diabetes disturbs glucose absorption and the release of gut hormones that regulate blood glucose levels. Finally, we test how loss of ACE2 influences gut barrier function to impact systemic inflammation and progression of diabetic retinopathy.